Investigating the metastatic drive in pancreas cancer

PROJECT SUMMARY
The unusually high metastatic proclivity of pancreas cancer is life-limiting for a majority of patients including
those diagnosed at early stages. A minority of patients nevertheless present with and succumb to locally
destructive disease. These distinct disease presentations and predilections for distant spread versus primary
tumor growth also suggest that the appropriate application of systemic versus local therapies might increase
their efficacy and prolong survival, even as we await the development of more effective targeted therapies. We
have undertaken a systematic effort to dissect the pathophysiologic mechanisms underlying the extreme
lethality of pancreatic ductal adenocarcinoma (PDA) primarily through the generation and study of genetically
engineered mouse models (GEMMs) of the disease that faithfully recapitulate the clinical syndrome,
histopathology, molecular features, and response and resistance to treatments seen in the human disease. We
have recently developed model systems that manifest the two disease phenotypes described above and used
these systems to uncover a metastatic program orchestrated by the Runx3/RUNX3 transcription factor that
governs the balance between cell division and dissemination. This program slows the proliferation of tumor
cells while increasing their ability to disseminate and successfully colonize distant sites. Runx3, acting in
concert with point-mutant Trp53 and distinct gene dosages of Dpc4/Smad4, suppresses local growth at the
expense of distant spread. In this proposal, we seek to further unravel the mechanisms underlying this decision
node in pancreas cancer disease behavior and the influences that distinct combinations of tumor suppressor
gene mutations can have on both the tumor epithelial cells and the metastatic niche. These aims will be
accomplished through the generation and characterization of novel GEMMs of PDA; identification of the
composition, target gene occupancy and transcriptional outputs of Runx3-associated transcriptional
complexes; and characterization of extracellular vesicles that mediate cell behaviors promoting metastasis.
Collectively, these investigations will reveal the mechanisms underlying the extraordinary competency of PDAs
to metastasize, identify new potential targets to disrupt this capability, and help inform the appropriate selection
of local vs. systemic treatment modalities already in use in the clinic.

Public health relevance
PROJECT NARRATIVE Understanding the fundamental mechanisms behind the metastatic drive of pancreas cancer and finding ways to intercept this process has great potential to impact survival. This information would also help evaluate the immediate and the longer-term risks of local vs. distant relapse of disease which would immediately impact patient management using already existing therapies. The investigations proposed here will rigorously test the principles underlying a mechanistic framework to explain the metastatic process in pancreas cancer and how best to apply the insights to the clinic.